Fructose: Substrate, Stimulus, or Both?

ABSTRACT
The alarming increase in rates of type 2 diabetes has remained unabated despite efforts to implement changes
to diet and other factors that undoubtedly play a role. One obstacle has been inconsistency in dietary
recommendations and, in particular, the role of fructose. Although population studies have linked excess
fructose consumption to type 2 diabetes and other metabolic disorders, questions remain regarding the role
played by fructose, in part because the precise mechanisms underlying these associations have not been
elucidated in humans. For example, multiple tracer studies have demonstrated that fructose consumption is
associated with increased rates of fatty acid synthesis (de novo lipogenesis [DNL]), but this finding is
questioned in view of studies in which very little labeled fructose was actually incorporated into newly
synthesized fat. We propose to resolve this paradox by determining whether fructose increases DNL by its
conversion to fat (direct effect) or if fructose is instead preferentially directed into synthesis of new sugar
(gluconeogenesis [GNG]), while other typical GNG substrates such as pyruvate are redirected into DNL in the
presence of fructose (indirect effect). Another paradox centers on how fructose leads to high levels of glucose
in the blood following a meal. In this grant we will test the hypothesis that meals high in fructose overwhelm the
GNG pathway and lead to increased glucose output into the blood. We further hypothesize that meals with
lower fructose content can be tolerated by persons with normal fasting insulin and glucose levels but not by
those with pre-diabetes. To address these questions, we will perform four one-day dietary studies in men and
women with either pre-diabetes or normal glucose and insulin levels. The study is based on the premise that
uncontrolled hepatic fluxes from excess fructose consumption play a key role in lipid- and carbohydrate-
associated dysregulation. We will employ a feeding paradigm using defined liquid meals and a combination of
oral and intravenous stable (not radioactive) isotopes, in tracer and non-tracer amounts, to simultaneously
measure fluxes in the GNG and DNL pathways in response to low or high fructose intake. We will also test
whether fluxes in these pathways are altered in pre-diabetic individuals compared to controls with normal
glucose and insulin levels. By simultaneously measuring the GNG and DNL pathways, this proposal has the
potential to both generate important advances in understanding the dynamics of postprandial fructose
metabolism and provide important mechanistic information to support or strengthen evidence-based nutritional
recommendations regarding limitations on fructose intake.

Public health relevance
NARRATIVE Although consumption of sugar, and in particular fructose, has been linked to diabetes and other chronic diseases, there is still considerable public debate over whether or to what extent fructose intake should be limited. Our proposed studies apply sensitive methodology under controlled conditions to resolve unanswered questions regarding the mechanisms by which fructose consumption contributes to excess fatty acid synthesis and elevations in blood glucose levels following consumption of meals containing fructose. These studies are designed to provide data to fill important knowledge gaps and support evidence-based dietary guidance.